The effectiveness of an autistic-delivered peer-support intervention for autistic adults: Community Autism Peer Specialist (CAPS) program

Abstract
Approximately 5.4 million adults in the United States (1 in 45) are believed to have autism spectrum disorder
(ASD), but there is a lack of services available to support them in reaching their full potential. Although typically
conceptualized as a childhood disorder, ASD-related service needs persist into adulthood. The core social and
communication impairments of ASD, reported difficulties with change, and a high rate of co-occurring mental
health conditions often result in limited participation in major life areas that are determinants of health,
including social and community participation, employment, housing, and transportation. The transition to
adulthood is not only associated with developmental challenges, but also a “services cliff” whereby supports
and services that were previously available through the education system are no longer available. Peer-
delivered interventions have emerged as a potent, evidence-based modality for enhancing outcomes among
other clinical populations, such as adults with serious mental illnesses, with effectiveness in enhancing social
networks, empowering participants, reducing the use of inpatient services, and increasing life satisfaction. At
present, there is limited research on the effectiveness of autistic-led peer support interventions, especially
those that target broad aspects of community functioning. The proposed study seeks to refine, manualize, and
test a pilot autistic peer support program aimed at supporting community participation among autistic young
adults, with the goal of preparing it for large-scale testing and future dissemination and sustainability. The first
aim of this proposal is to enhance the structure of a pilot autistic-peer delivered intervention (Community
Autism Peer Specialists, or CAPS) that is currently in use as a Medicaid-reimbursed service in Philadelphia.
This will include developing a manual and fidelity tool to facilitate evaluation and systematic implementation.
The second and third aims are to conduct a hybrid type 1 effectiveness-implementation randomized controlled
trial with 40 young autistic adults to test the feasibility and acceptability of the intervention and research
procedures, while also examining proposed target mechanisms of action (e.g., self-efficacy, working alliance,
perceived social support) and clinical outcomes such as community participation, loneliness, and resilience.
This work will gather additional evidence and implementation information to support a fully-powered R01-
funded clinical trial. The proposed efforts will involve substantial engagement of a diverse group of autistic
adults in all phases along with multiple community partners, including a Medicaid payer. The project has
tremendous potential to expand service options for autistic adults and is uniquely poised to have broad,
scalable impact.

Public health relevance
PROJECT NARRATIVE The number of autistic adults reached 5.4 million in the United States in 2017 and is projected to continue to rise, but evidence-based practices to optimize their health and well-being are limited and poor outcomes are common. This study will leverage existing infrastructure to finalize development of a novel support service provided by peers with lived experience, incorporating input from autistic peer specialists, autism researchers, peer support researchers, and experts in peer support training. We will then conduct a pilot randomized controlled trial to examine the effectiveness of the service while also examining feasibility, acceptability, and implementation procedures in preparation for future large-scale testing and dissemination.